MALDI & ESI & LC ESI QQTOF AND LC ESI LTQ-ORBITRAP MS TRAINING

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. Our laboratory makes extensive use of the Applied Biosystems API QSTAR(tm) Pulsar i QqTOF mass spectrometers for the characterization of complex biological samples obtained from collaborative research projects. During the current reporting year, several staff members have been provided training on the design and use of the QSTAR for the analysis of samples via ESI-MS/MS and LC-ESI-MS/MS. They have been trained in the use of batch parameter files, processing scripts and automated IDA MS/MS functions that have been optimized for typical protein digests. LC instruction has been provided and includes theory and application of column packing methodology, LC separation parameters and ESI interfaces. Former Resource staff member Dr. Seward prepared an excellent powerpoint guide to instrument operation and data processing that is distributed to all group members when they are beginning to use these systems. After the Thermo-Fisher LTQ-Orbitrap MS system was installed in the spring of 2007, Drs. Leymarie and Infusini took on responsibility for the system, attended the Thermo training course and began to introduce other group members to its hardware and software feaures. Dr. Infusini completed his work at BUSM and moved to Australia in fall 2009 and his role has been taken on by Dr. Voillard-Bourgoin.